Mechanisms of operant reward seeking in prefrontal somatostatin-expressing interneurons

Project summary
Substance use disorder (SUD) is a debilitating disorder characterized by severe alterations in the neural circuits
of reward. Among others, the gamma aminobutyric acid (GABA) system is a critical component of the pathology
of SUDs. While historically studied in the context of alcohol use, the GABAergic system is now gaining more
attention for its roles in mediating the rewarding properties of other drug types (such as opioids) and natural
rewards. However, in comparison to other systems like dopamine, our understanding of the GABAergic mecha-
nisms of reward seeking is far less complete. Like the fields of reward and addiction, a vast majority of studies
of fear memory, which is where our previous work was situated, generally cast GABAergic neurons aside as
simple gain modulators and instead focus on glutamatergic neurons as the main memory substrate. As a result,
much less is known about whether and how GABAergic neurons themselves encode aversive memory. We
pioneered this area and revealed that a population of somatostatin-expressing interneurons (SST-INs) in the
prelimbic (PL) region of the rodent medial prefrontal cortex is a prominent substrate of fear memory. We also
identified a second orthogonal PL SST-IN population which is activated by a single intraperitoneal morphine
injection that drives positive valence. While these results hint towards a role for PL SST-INs in reward, the mech-
anisms that underlie this function are unknown. Moreover, how PL SST-INs may differentially regulate different
reward behaviors, such as natural and drug reward seeking, is unstudied. We will address these gaps by pursu-
ing three Aims. 1. Reveal the in vivo dynamics, behavioral contributions, and map the circuits of PL SST-INs that
drive natural and drug reward seeking. We will perform Miniscope imaging of PL SST-INs across natural and
drug reward seeking to reveal when and how they are activated in self-administration tasks. Next, we will perform
intersectional activity-dependent neural tagging and in vivo optogenetics to determine the specific contributions
of tagged neurons to natural and drug reward seeking behaviors. Last, we will use nested optogenetics-based
neural tagging to reveal the organization and brain-wide projections of PL projection neurons disinhibited by
natural and drug reward-tagged SST-INs. 2. Determine the circuit plasticity mechanisms of operant natural and
drug reward seeking in PL SST-INs. By using intersectional activity-dependent neural tagging and optogenetics-
assisted brain slice physiology, we will reveal the synaptic and intrinsic plasticity mechanisms as well as the
specific microcircuit alterations related to natural and drug reward seeking in SST-INs. 3. Reveal the transcrip-
tional profiles of PL SST-INs driving operant natural and drug reward seeking. We will isolate nuclei from PL
SST-INs tagged in response to natural and drug reward seeking and subject them to single-nucleus RNA-seq.
Comparisons will be made between natural and drug reward-tagged as well as non-tagged PL SST-INs to reveal
reward-specific transcriptional programs. Overall, results from this work will provide important fundamental in-
sight to the mechanisms of natural and drug reward seeking in PL SST-INs.

Public health relevance
Project narrative A prominent feature of substance use disorder is disruption of GABAergic transmission. Despite this, nearly all studies focusing on the cortical mechanisms of both natural and drug reward seeking have focused on excitatory neurons, while largely overlooking contributions of GABAergic neurons. In this proposal, we are switching fields to reward and addiction to gain an understanding of the prefrontal GABAergic circuit mechanisms underlying natural and drug reward seeking by using in vivo imaging, functional, and molecular approaches.